PET MEASURE OF CEREBRAL BLOOD FLOW CORRELATES OF MEMORY IN POSTRAUMATIC STRESS

The purpose of this study is to measure cerebral blood flow with positron emission tomography (PET) and H215O during a short-term (declarative) verbal memory task in patients with posttraumatic stress disorder (PTSD) and healthy subjects. The hippocampus is felt to play an important role in short-term verbal memory. Previous PET studies have shown activation of the hippocampus with short-term declarative verbal memory tasks. We have previously shown smaller hippocampal volume and deficits in short- term declarative verbal memory function in patients with combat-related as well as severe childhood abuse-related PTSD. The current project will extend these studies by examining function of the hippocampus in patients with PTSD. We hypothesize that PTSD patients will have a blunted hippocampal blood flow response to short-term verbal (declarative) memory tasks relative to controls.